Determining the subcellular and molecular players in neutrophil trogocytic killing of the sexually-transmitted parasite Trichomonas vaginalis

PROJECT SUMMARY
Trichomonas vaginalis is a unicellular, motile protozoan parasite responsible for the 3rd- most common
sexually-transmitted infection in the US and worldwide. While around half of T. vaginalis infections are
asymptomatic, symptoms of the infection can range from vaginitis and frothy discharge, to male and female
infertility, pre-terms births, increased incidences of malignant cervical cancers, and increased spread of HIV. T.
vaginalis was recently classified as a neglected infection in the US, as very little is known about its modes of
pathogenesis, how the immune system clears the parasite, or whether immunological memory is established
following infection. Rising drug resistance and lack of a vaccine demand further research into the parasite- host
interactions: specifically, what effective immunity to the parasite entails. It has long been known that immune-
cells called neutrophils are crucial for immune- clearance of T. vaginalis, however it was only recently
discovered that neutrophils use a previously unknown antimicrobial mechanism called trogocytosis (trogo= to
nibble) to kill this relatively large, motile pathogen. Neutrophil trogocytosis of T. vaginalis was found to be a
contact-dependent process, in which neutrophils surround the parasite, and internalize multiple fragments
("bites") of T. vaginalis prior to parasite death. However, the molecules that mediate neutrophil-parasite cell-
cell contact to initiate trogocytosis are unknown, as are the cellular mechanisms that neutrophils use to "nibble"
and degrade parasite "bites," causing death of the parasite. As human serum is required for neutrophil
trogocytosis of T. vaginalis, we hypothesize that human serum factors crosslink parasite surface antigens to
immune- receptors on neutrophils to establish cell-cell contact and initiate trogocytosis. We also hypothesize
that neutrophil toxic granules containing membrane- degrading factors are mobilized to the neutrophil- parasite
interface to mediate nibbling, and that lysosomal degradation of parasite "bites" is required for sustained
nibbling to kill the parasite. We will test these hypotheses using a series of genetic loss- of- function
experiments, using CRISPR-Cas9 to functionally delete candidate genes in a cell-line (HL-60s) that is a
developmental precursor to neutrophils, and then differentiate the cells into neutrophil-like cells for functional
tests. Our preliminary data show that HL-60s are a suitable and tractable model for studying trogocytic killing of
T. vaginalis. We will also perform imaging experiments in the presence of lysosomal markers, and perform
trogocytosis assays in the presence of lysosomal inhibitors. Altogether, these studies will outline the
subcellular and molecular mechanisms that human- immune cells use to effectively clear T. vaginalis,
information that will be invaluable in informing vaccine design. Furthermore, these studies will contribute
foundational knowledge regarding a novel antimicrobial process.

Public health relevance
PROJECT NARRATIVE The human-infective parasite Trichomonas vaginalis causes an extremely prevalent sexually-transmitted infection that is associated with serious adverse sexual/ reproductive health consequences, however the immune response to the parasite is mostly uncharacterized. This proposal seeks to determine the subcellular and molecular mechanisms that immune cells at the front-line of T. vaginalis infection use to effectively kill the parasite, helping to illuminate parasite-associated immuno-pathologies and give clues for what effective vaccines against T. vaginalis should entail. It will also uncover the molecular players in a novel antimicrobial process that immune cells use to kill T. vaginalis: trogocytosis.